Affect Regulation Training for Pregnant Smokers

DESCRIPTION (provided by applicant): Recent data indicate that approximately one-third of women of childbearing age smoke cigarettes, and 25-50% of women smoke during pregnancy. Cigarette smoking during pregnancy is a significant public health issue that can have profound effects on women's health and the health of their developing fetus. Smoking among pregnant women is associated with high levels of negative affect, which play a key role in the maintenance of smoking behavior and in difficulty quitting smoking during pregnancy. Despite the clear role of negative affect in the maintenance of smoking among pregnant women, and while this issue has received increased attention by clinicians and researchers, we know of no smoking cessation intervention that combines coping skills and emotion regulation approaches to address the role of negative affect in smoking cessation. Smoking cessation treatment strategies that have demonstrated effectiveness in regular smokers have not translated into effective treatment strategies for pregnant women, particularly low-income pregnant women. The goal of this project is to develop and test an affect regulation smoking cessation intervention for low-income pregnant smokers. The major aims of this project will be addressed in two sequential phases. In Phase 1, we will develop two 8-session smoking cessation treatment manuals including: (a) Affect Regulation Training and Cognitive Behavioral Treatment (ART+CBT) and Cognitive-Behavioral Treatment (CBT). In Phase 2, we will conduct a randomized clinical trial pilot study (Total N = 60) to compare the ART+CBT and CBT conditions on: a) the feasibility and acceptability of the interventions, (b) the impact of these interventions on smoking cessation rates at post treatment and at 6-months post-quit date, (c) affect regulation skills, and (d) negative affect among pregnant smokers. The long-term goal of this proposed research is to increase smoking cessation rates among pregnant smokers, which would provide significant long-term health benefits for both mothers and their infants. This Stage 1 application will be used to generate feasibility and preliminary efficacy data, setting the stage for a Stage II efficacy trial.